Dissecting local (N) and long range (Z) circuit modules within the spinal cord

Project Summary/Abstract:
Spinal cord circuits are the final step in motor computations and are a site where descending signals are
integrated with sensory cues to drive motor behavior. Eleven cardinal spinal interneuron types have been
identified with distinct developmental origins, neurotransmitter phenotypes, and ipsi- versus contra-lateral
connections. Elegant genetic approaches have targeted these cardinal interneurons revealing roles in motor
control, but understanding of how spinal neural networks comprised of heterogenous cells from multiple cardinal
domains function together to control features such as precision, coordination, and automaticity of motor
behaviors remains unclear. This grant focuses on a recent discovery (Osseward et al., Science 2021) that each
cardinal interneuron population is profoundly divided into genetically-distinct local and long-range neurons (1).
The goal of this grant is to determine if these local/long range divisions of cardinal neurons correspond to distinct
circuit modules for motor control.
Transcriptomic profiling revealed a code spanning each cardinal interneuron domain in which medially-located
neurons with short range connections are marked by NeuroD2 (called N-type) and laterally-located cells with
long range projections express Zfhx3 (called Z-type). Here this proposal will test whether these N/Z-markers
define functional neural units for controlling coherent features of motor behavior by comparing the connectivity,
function, and neural-activity of N-type and Z-type cells within two distinct cardinal interneuron populations:
inhibitory V1 and excitatory V2a neurons. This grant hypothesizes that long range Z-type neurons have critical
functions related to “broadcasting” motor commands across multiple spinal segments to facilitate dexterity and
interlimb coordination, whereas N-type neurons process local information for rapid reflexes and L/R limb control.
Although inhibitory-V1 and excitatory-V2a interneurons are physiologically different, this grant explores the
possibility that the N- versus Z-cell types from each cardinal class may have related functions that transcend
even their neurotransmitter status. By defining the foundational organizational features of motor circuits, these
studies may reveal a higher logic for how circuit modules are constructed with different cardinal neuron types.
To explore the innovative hypothesis that functional units span cardinal cell types, a novel set of mouse
intersectional genetic tools for labeling/targeting the N/Z divisions of the V1 and V2a neurons was generated. A
new method for multi-electrode in vivo neuronal recording of spinal neurons in behaving animals was also
established. Aim 1 (outputs) and Aim 2 (inputs) will define V1- and V2a-N/Z connections to understand the
anatomical similarities and differences of N/Z-neurons within two distinct cardinal populations. Aim 3 will perturb
the function of V1- and V2a-N/Z subtypes to understand their role in motor behavior. Aim 4 will record the neural
activity of V1- and V2a-N/Z subtypes during motor behavior to determine whether their activity is linked to specific
motor functions. These studies aim to reveal entirely new organizational features of spinal motor circuitry.

Public health relevance
Project Narrative: We discovered that each of the cardinal interneuron classes of the spinal cord can be divided into two subtypes - one with local connections and one with long range connections, based on a conserved set of genetic signatures. These findings reveal a previously unappreciated organizational principle of the spinal cord, but lead to the question why did nature duplicate the cardinal cell groups creating these subsets? This grant will examine whether these newly identified long/short range connectivity divisions of the cardinal classes represent distinct neural units for motor behavior.